Characterization of a ubiquitin binding domain in interferon pathway protein RIOK3

Project summary
This goal of the research proposed here is to explore the nexus of the well-characterized polyubiquitin
signaling network that is activated during the cellular antiviral response and the functional implications of
ubiquitin binding by innate immune protein RIOK3. Our laboratory has determined that RIOK3 is essential
for initiating a robust interferon response to Rift Valley fever virus infection and other immunogenic stimuli in
epithelial cells. We have also demonstrated that the pre mRNA for RIOK3 is subject to alternative splicing
following immune stimulation. This alternatively spliced mRNA encodes a truncated version of RIOK3 that
contains the N-terminal domain, but lacks the kinase domain. Intriguingly, expression of this truncated
protein inhibits the cellular interferon pathway response in epithelial cells, but activates the NFkB pathway.
Prior observations from other groups demonstrated that RIOK3 exhibits high affinity for K63-linked
polyubiquitin chains, and this putative ubiquitin binding domain (UBD) resides in the N terminal region.
Together with our data on the functions of RIOK3 isoforms, we hypothesize that the UBD guides RIOK3 to
its essential cellular interaction partners during the cellular immune response. Furthermore, the truncated
RIOK3 makes the same protein-protein interactions mediated by the UBD, but cannot fulfill the immune
signaling function because it lacks its kinase domain. To test this hypothesis, we propose to precisely map
the UBD of RIOK3 and characterize the phenotypic consequences of deletion or mutation of the RIOK3
UBD. We will test UBD mutants in vitro and in cell culture for ubiquitin binding properties and phenotypic
effects on innate immune responses. Upon completion of these studies, we will have structurally and
functionally mapped a novel protein interaction domain in RIOK3 which will shed light on its roles in the
cellular antiviral response, with potential future applications in treatment of viral or immune diseases.

Public health relevance
Project narrative Upon viral infection of mammalian cells, immediate generic responses are initiated by the cell to attempt to suppress the infection. The research proposed here is designed to shed light on the functions of one poorly understood protein, RIOK3, that is important in this response. This research will enhance our understanding of some immune responses that have potential applications for treatment of viral or autoimmune diseases.